MINORITY PREDOCTORAL FELLOWSHIP PROGRAM

Briefly, my interests span the fields of linguistics and anthropology. The link between these areas is my desire to examine the relationship between child language development and language preservation. The reason I am interested in research on this relationship is because it seems to me that a language cannot be preserved without new generations acquiring the language as native speakers. Most research has viewed preservation from a socio-cultural or education perspective, focussing primarily on adult-oriented processes. I propose, however, to approach preservation from this new direction and study language development in children. In particular, I hope to work with a Native American community in an attempt to uncover variables involved in both failed and successful language acquisition.